Autism Complexity and Parental Wellbeing: The Role of Care Coordination in Promoting Health Equity

Project Summary
The overall goal of this proposal is to determine the influence of autism spectrum disorder
(ASD) care coordination services on parent health and stress according to geographic and
sociodemographic factors. Specifically, the aims of this study are to establish an assessment of
ASD severity that reflects co-occurring conditions, determine the impact of care coordination on
the association between child ASD and parent outcomes, and delineate variation in the impact
of care coordination on parent outcomes by sociodemographic influences, (i.e., race/ethnicity,
rural/urban areas, Health Professional Shortage Areas).
To achieve the aims of this proposal, we will merge the 2016-2019 National Survey of Children’s
Health (NSCH) to create the largest, nationally representative dataset that includes child,
parent, and healthcare-related variables. The combined sample includes 3,313 parents of
children with a current ASD diagnosis. The Health Resources and Services Administration
(HRSA) designations of primary care and mental health HPSAs will be analyzed to evaluate the
interrelation of multi-level ASD influences from a health equity framework. A moderated-
mediation model of ASD care coordination will be used to test for sociodemographic interaction
effects (i.e., moderation) in the degree to which care coordination explains the association
between ASD complexity and parent health and stress (i.e., mediation).
Completion of these aims will provide a direct response to federal initiatives to standardize and
evaluate child healthcare coordination. The Medicaid Services Investment and Accountability
Act (MSIAA) of 2019 will allow states to offer optional benefits that include care coordination
services for Medicaid-eligible children with medically complex conditions beginning in 2022.
Qualifying conditions under the MSIAA includes only “severe autism”, which excludes children
with mild or moderate autism that may have multiple other co-occurring conditions. Further,
there is broad inter-state variability in the availability and requirements for care coordination
offered in available health plans (Barth, 2019). The Department of Health and Human Services
(2020) is currently attempting to evaluate best practices in care coordination among out-of-state
providers for children with medically complex conditions, as not all states allow the service. Our
findings will contribute to initiatives for community-informed ASD care coordination.

Public health relevance
Project Narrative The overall goal of this proposal is to identify the influence of healthcare coordination on the association between autism spectrum disorder (ASD) and parent health and stress using a more robust, comprehensive assessment of ASD severity that includes co-occurring conditions, ASD complexity. Further, the role of healthcare coordination will be evaluated in the context of geographic and sociodemographic factors to identify disparities in healthcare access among marginalized and underserved populations. Our central hypothesis is that the degree to which care coordination affects the relationship between ASD complexity and parent outcomes will vary according to sociodemographic factors (i.e., race/ethnicity, rural/urban areas, HPSAs).